Pathogenicity of ethanol tolerant strains of Candida albicans in the oral cavity

Summary
The fungus Candida albicans is an opportunistic pathogen and a common colonizer of the
human oral cavity. In healthy individuals, the organism exists in homeostasis with its host as a
component of the microbiota. If the host becomes compromised, C. albicans can cause
oropharyngeal candidiasis (OPC) and promote the development other types of oral disease
such as oral cancer. Patients with a variety of oral diseases are known to harbor C. albicans
strains with higher production of secreted degradative enzymes, such as phospholipases and
proteases. These enzymes are known virulence factors of C. albicans. Thus, C. albicans strains
found in the oral cavity of patients may exhibit elevated virulence.
Alcohol use is another factor that favors the development of oral cancer. Alcohol consumption
has many effects on the host and could also affect the microbiota of the oral cavity since
organisms would be transiently exposed to alcohol. When C. albicans strains with elevated
alcohol tolerance were selected by evolution during laboratory culture, the strains were found to
upregulate the expression of genes encoding phospholipases, lipases and proteases. These
observations suggest the model that strains with elevated expression of degradative enzymes
have altered interaction with the host due to high expression of virulence factors.
The proposed research will investigate the interaction of alcohol tolerant C. albicans strains with
the oral epithelium. The experiments described in Specific Aim 1 will utilize cultured human oral
epithelial cells to determine whether alcohol tolerant strains show increased pathogenicity when
cocultured with human cells, with or without alcohol. The experiments described in Specific Aim
2 will utilize the cortisone acetate immunosuppressed mouse model of OPC to measure the
ability of alcohol tolerant strains to produce damage and disease in an animal model.

Public health relevance
Narrative The fungus Candida albicans is a common colonizer of the mouth and a major cause of oropharyngeal candidiasis. C. albicans strains selected for higher tolerance to alcohol were found to express higher levels of degradative enzymes, suggesting that such strains could have altered interaction with the host. This research will investigate interactions between alcohol tolerant C. albicans and host oral epithelium.